Core 1: Administrative

Summary The main objective of the Administrative Core of this Program is to provide support and assistance to all scientists and administrative personnel participating in the three Projects and two Scientific Cores of this Program Project. It is imperative that all teams involved in this Program integrate seamlessly to establish a symbiotic unit, particularly given the uniquely integral functions that each Project and Core Leader will provide to the overall Program. Under the direction of Dr. Allis, his laboratory's administrator, Marisa Cerio, will manage this core. Ms. Cerio has demonstrated experience in the integration of many projects across institutions worldwide, including a well-established and ongoing collaboration between all Project leaders outlined in this proposal.

Public health relevance
Project Narrative The Administrative Core is responsible for providing clerical support and assistance to all scientists and administrative personnel participating in the three Projects and two Scientific Cores of this Program Project. The role of this core is essential in the success of a well-integrated Program.